Tumor pyruvate kinase as key regulator of cancer metabolism

The project seeks to understand the role of pyruvate kinase as regulator of cancer metabolism. Insight into glycolytic and TCA cycle flux from metabolic profiles of cancer cell lines will reveal new drug targets and generate new regimes for diagnosis and treatment of cancer patients.

Public health relevance
The impact of this study is extremely high; this work could entirely change the field of cancer metabolism. I will provide a platform to study the complex network of central carbon metabolism with the possibility to follow changes upon tumor progression or perturbation by interference with drugs or molecular biology tools. The work proposed brings mechanistic insights into a key regulator of the tumor metabolome and paves the way to diagnose and treat not only mammary gland but also numerous other carcinomas